Developing a Prediction Model to Improve End‐of‐Life Prognostication and Hospice Referral in Parkinson's Disease

Project Summary/Abstract
Parkinson's disease (PD) is the second most common neurodegenerative illness, affecting approximately 1.5
million Americans, and is the 14th leading cause of death in the United States. There are currently no Medicare
Guidelines for hospice referral specific for PD and we believe the lack of appropriate models or guidelines for
clinicians is one of the prime factors leading to the disproportionately high rates of in-hospital deaths and low
rates of hospice referrals in this population. Our long-term goal is to improve end-of-life outcomes for persons
living with PD and their family caregivers, including improving the rates of hospice referrals and duration of
hospice use. We hypothesize that currently available hospice guidelines are underutilized and that, even when
used, significantly underestimate 6-month mortality and miss important predictors of mortality in this
population. We further hypothesize that data currently available in the Minimal Data Set (MDS – a federally
mandated clinical database of nursing home residents) and National Death Index (NDI) can be used to develop
a more accurate prediction model. Notably, Mitchell et al. utilized a similar approach in dementia to develop the
Advanced Dementia Prognostic Tool (ADEPT), a risk score demonstrated to be more accurate than Medicare
Guidelines for dementia. Toward developing a valid prognostication model and risk score, we will follow a
model building and validation structure outlined by Steyerberg that includes statistical methodology for the
consideration of missing values, model specification, parameter estimation, performance measurement,
reproducibility, generalizability, and clinical usefulness. We will accomplish the objectives of this proposal
through two Specific Aims: 1) Develop a predictive model of 6-month mortality in persons living in nursing
homes with PD using the Minimum Data Set and the National Death Index; and 2) Compare the accuracy of
our PD-specific prediction model to currently available Medicare Hospice Guidelines. The approach is
innovative as the first study to apply this data-driven approach to PD end-of-life prognostication and uses state
of the art machine learning and modeling approaches, and evaluation and interpretation tools, to achieve a
clinically useful model. The proposed research is significant as the results of this proposal will create the first
evidence-based and PD-specific risk scores for hospice referral and will provide the first systematic analysis of
the accuracy and use of currently available hospice guidelines in this population. We anticipate that the results
of this work will have a rapid and direct impact on patient care and will also create a foundation for future
studies to improve hospice referrals and prognostication in this population as well as a foundation for future
prospective studies in both nursing home and community-dwelling cohorts.

Public health relevance
Project Narrative: Hospice provides a package of services to patients nearing the end of their lives with services intended to maximize comfort, optimize quality of life, support families, and reduce aggressive medical interventions that may increase suffering without significantly improving or changing the course of their illness. Although Parkinson’s disease (PD) is the second most common neurodegenerative illness and the 14th leading cause of death in the United States, there are currently no guidelines available for clinicians to predict which PD patients should be referred for hospice care and hospice is underutilized in this population. The goal of the current proposal is to use currently available data to create a predictive model that would improve clinicians’ ability to accurately assess which patients with PD living in nursing homes should be considered for hospice.